BCCMA: Targeting Osteoarthritis Pain and Progression: Preclinical OA models of vagal nerve stimulation to reduce pain and progression of OA

Project Summary:
OA is a leading cause of chronic pain and disability in our Veterans who develop OA at significantly younger
ages and in higher numbers than non-Veterans. Consequently, the disease burden of OA is disproportionately
borne by Veterans and the VA Healthcare system (VAHCS). Currently there are no disease modifying anti-
osteoarthritis drugs (DMOAD) due in part to a historical focus on identification and tracking of radiographic OA
outcomes rather than pain and function-related disease pathways. Our integrated research program in the Treat
Osteoarthritis Pain and Progression (TOPP) Collaborative Merit program will test the central hypothesis that
variability in OA pain and structural progression is related to heterogeneity in the cellular and molecular
responses of bone, cartilage, and synovium to inflammation and joint loading. This Collaborative Merit will
pursue two overarching Specific Aims: Aim 1: To improve understanding of osteoarthritis (OA) pathogeneses to
enable development of targeted therapeutic approaches, and Aim 2: To establish preclinical data for new
therapeutic targets to reduce pain and prevent OA progression. Using early and late OA clinical cohorts
prevalent in the VAHCS and joint injury animal models to test novel therapeutic approaches will require
coordinated multidisciplinary bench to bedside work for that no single project can adequately address. Further,
we will couple results from treatment efficacy of vagal nerve stimulation (VNS), targeting nerve growth factor
(NGF), and targeting mast cells in preclinical OA animal models with human OA phenotyping and stratification
will allow for rapid transition to clinical trials in OA and joint injury. The goal of Project 4 is to determine if
transcutaneous vagal nerve stimulations (tVNS) reduces pain and prevents structural progression in
acute and chronic preclinical OA models. VNS, currently FDA approved for epilepsy and depression,
activates a cholingeric anti-inflammatory pathway, driving production of acetylcholine (Ach) in nerves and non-
neuronal cells, and provides a strong systemic anti-inflammatory effect that reduces synovial inflammation and
joint pain in mouse models of rheumatoid arthritis. Within the joint, cholinergic fibers innervate the synovium,
trabecular bone, and periosteum and studies suggest that the parasympathetic nervous system modulates
nociceptive pain and possibly OA pathogenesis. Nicotinic acetylcholine receptor α7 (α7NAChR) in macrophages,
T cells, and chondrocytes may mediate VNS effects. Based on these and our exciting preliminary data showing
improved pain after 4 weeks of VNS in the destabilized medial meniscal injury model, our hypothesis is that tVNS
reduces pain and prevents structural progression in OA. We will test this hypothesis in three aims: (1) Test if
tVNS reduces pain in acute and chronic mouse models of OA, (2) test if tVNS slows structural progression of
acute and chronic mouse models of OA, and (3) Integrate outcomes of tVNS in OA animal models with human
OA phenotyping to identify biomarkers predictive of VNS response or OA progression. Results will have a
substantial impact on Veteran Health by providing critical preclinical evidence that VNS improves pain and
prevents progression of OA and will provide important human biomarkers to improve selection of patients with
early or late-stage OA for clinical trials of VNS and other emerging treatments.

Public health relevance
Project Narrative Osteoarthritis (OA) is a leading cause of chronic pain and disability in our Veterans who develop OA at significantly younger ages and in higher numbers than non-Veterans. There are no disease modifying anti- osteoarthritis drugs (DMOAD) or treatments. This proposal will determine if vagal nerve stimulation delivered for 10 minutes a day will improve pain or prevent progression in two preclinical models of post-traumatic OA.